Production Assistance for Cellular Therapies (PACT)- Cell Processing Facilities Cell manufacturing and process development services for RSA PCT0035-01: Preclinical Development of PB-derived iTregs

The objective of this project is to develop an optimized approach to isolation and expansion of peripheral blood-derived iTregs.